Center for Inherited Disease Research--GWAS for exfoliation Syndrome and Glaucoma

Center for Inherited Disease Research--Genome Wide Analysis Study (GWAS) DNA sequencing for exfoliation Syndrome and Glaucoma